Renewal of Centers of Biomedical Research Excellence (COBRE) (Phase 2) CNTN - Resubmission

SUMMARY/ABSTRACT
Overall
Nevada (NV) is one of the 24 Institutional Development Award (IDeA) states affected by restricted research
capacity. The overarching goal of our Center of Biomedical Research Excellence (COBRE) Center for
Neurodegeneration and Translational Neuroscience (CNTN) is to establish translational neuroscience research
infrastructure in Southern NV to develop innovative diagnostic methods and therapeutic interventions that can be
applied across neurodegenerative disorders (NDD) and in diverse populations. The CNTN is highly significant
for State representatives given the upcoming needs of age-related NDD healthcare due to the sustained increase
in the population of NV, including retirees.
Our thematically cohesive, multidisciplinary team comprises investigators from both the Cleveland Clinic Lou
Ruvo Center for Brain Health, Las Vegas (LRCBH), and the University of Nevada Las Vegas (UNLV). During the
first five years of COBRE support, the CNTN has transformed the environment for translational neuroscience
research in Southern NV. The main accomplishments of CNTN Phase 1 are: 1- the creation of a Brain Imaging
Department at LRCBH dedicated to research endeavors; 2- the building of a research cohort comprising NDD
subjects who are deeply phenotyped; 3- the establishment of a Data Management and Statistics Core; 4- the
inauguration of a Department of Brain Health, whose Founding Chair was a CNTN Junior Investigator (JI); 5- the
forming of a Community Advisory Board to assist with community outreach activities aimed at inviting diverse
individuals to volunteer in clinical research projects; and 6- the increase in the critical mass of investigators. A
promising group of JIs have leveraged the resources compiled by the CNTN to carry out highly innovative
research projects. All the JIs have graduated from the CNTN program with independent funding and promotion
within local or external high caliber institutions. Our Assessment Unit has created new assessment methods
based on a Science of Team Science approach to assess the performance of each individual CNTN Core and JI.
They demonstrated that increasing the size of a scientific networking results in the inflation of scientific products.
In Phase 2, the CNTN intends to develop the resources and processes necessary to reach sustainability. For
this, we are revising the CNTN leadership to tackle growing responsibilities. The evaluation reports produced by
our Assessment Unit will be utilized to elaborate our strategy, monitor progress, and make eventual adjustments.
Specifically, we plan to foster infrastructure development, strengthen the career development of CNTN
investigators, launch a pilot project program, and stimulate research productivity. We anticipate that our efforts
will result in new collaborations with academic and industry partners, which will put the CNTN on the path for
sustainability.

Public health relevance
NARRATIVE Overall Our Center for Neurodegeneration and Translational Neuroscience (CNTN) is transforming the translational neuroscience research environment in Southern Nevada. In Phase 1, the CNTN has developed robust research infrastructure that was leveraged by local investigators to carry out innovative biomedical research projects focused on neurodegenerative disorders (NDD). In Phase 2, we ambition to develop the resources and processes necessary to reach sustainability by utilizing the evaluation reports produced by our talented Assessment Unit to elaborate our strategy, monitor progress, and make eventual adjustments to our strategy.